Planning for Na-GST-1 Hookworm Vaccine Phase 2 CHIM Efficacy Trial

Project Summary/Abstract
This R34 grant proposal is to plan a clinical trial that will test the proof-of-concept that the lead candidate
hookworm vaccine antigen, Na-GST-1, can have a meaningful biological impact on hookworm infection. This
trial will utilize an innovative paradigm for early assessment of investigational vaccine antigens by challenging
human volunteers using a controlled human infection model (CHIM) after vaccination. Hookworm is one of the
most important parasitic infections, with over 400 million people infected worldwide, most with the Necator
americanus species. The clinical hallmark of hookworm infection is iron deficiency anemia resulting from
intestinal blood loss. Na-GST-1 is a critical component of the blood-feeding pathway of N. americanus and was
selected for clinical development based on its protective efficacy in animal trials. Recombinant Na-GST-1,
formulated on Alhydrogel, has been shown to be safe when administered to healthy adults and children in
Phase 1 trials. In a small pilot Phase 2a CHIM proof-of-concept study conducted in hookworm-naïve
volunteers, Na-GST-1/Alhydrogel administered in combination with the CpG 10104 immunostimulant, provided
significant protection against a single challenge with NaL3 larvae. In the proposed study, healthy
hookworm‐naïve adult volunteers will be vaccinated with Na-GST-1/Alhydrogel/CpG 10104 according to
different doses followed by challenging them with repeated doses of infective N. americanus larvae to assess
the effect of vaccination on infection, as assessed by parasitologic, immunologic and hematologic parameters.
Repeated challenges will more faithfully mimic exposure conditions in endemic areas, and will also provide
more insight into the duration of protection afforded by the vaccine.
Traditionally, proof-of-concept for novel investigational vaccines is tested in large field trials in endemic areas.
These can take considerable time depending on the incidence of infection in the control arm of the study. The
objective of this R34 proposal is to plan a study in which proof-of-concept is tested early in the clinical
development of new vaccines for hookworm, one of the most prevalent and important of the Neglected Tropical
Diseases. The results of this trial will permit critical Go/No-Go decisions to be made on further development of
the Na-GST-1 hookworm vaccine, prior to conducting larger, more costly Phase 2 and 3 trials.

Public health relevance
Project Narrative We will plan the implementation of a Phase 2a clinical trial in healthy, hookworm-naive adults to evaluate proof-of-efficacy of the experimental hookworm vaccine, Na-GST-1/Alhydrogel, administered with the CpG 10104 immunostimulant. We will utilize an innovative controlled human infection model to challenge vaccinated volunteers with repeated doses of Necator americanus hookworm larvae to better mimic natural exposure to assess whether vaccination with this candidate antigen has a significant impact on infection with this parasite. This will facilitate and inform future decision-making on advancing this hookworm vaccine into later-stage clinical trials, particularly before large field efficacy studies in children, thereby saving time, expense, and exposure of human research subjects – especially children – to potential risk.